Scripps Clinical and Translational Science Hub

The Scripps Research Translational Institute (SRTI) is the foundation for the Scripps hub and is dedicated to accelerating science that will improve human health. SRTI’s emphasis on genomics, digital medicine, and informatics/analytics fosters a multi-dimensional understanding of individualized human health. The Scripps hub has previously included the Scripps Research Institute (SR) and Scripps Health (SH) as principal partners, including Rady Children’s Institute of Genomic Medicine (RCIGM) for genomic medicine initiatives and California Institute for Medical Research (Calibr) for drug repurposing / discovery. In the new CTSA cycle, our partners have expanded to include San Diego State University (SDSU), enabling us to combine forces in computer science, artificial intelligence, and biosensors. SRTI’s expertise in genomics was highlighted during the pandemic. Digital medicine has been one of SRTI’s core strengths, having pioneered the first remote, site-less digital clinical trial and now expanding this methodology to address many other medical conditions such as health during pregnancy and sleep disorders. The Scripps hub will innovate clinical and translational science to improve human health across the lifespan. The hub will provide a nurturing environment for education, training, and career development with a focus on individualized health domains of genomics, digital medicine, and biomedical informatics, to empower tomorrow’s workforce.

Public health relevance
The Scripps hub brings together Scripps Research and its partners Scripps Health, Rady Children’s Genomic Medicine Institute, and newly added San Diego State University, along with many collaborating entities, to innovate and transform translational and clinical science. The three principal focus areas of SRTI—genomics, digital medicine, and informatics/analytics—are interdependent, and foster a multi-dimensional understanding of human beings, which is the true foundation of individualized medicine. The Scripps hub will relentlessly pursue innovations in translational and clinical science to promote accuracy, individualism, and democratization, with deep academic and industry collaborations, fully integrating the voice of the community and patients, with a paramount goal of improving health.